African Rare Diseases Initiative (ARDI): Advancing Genomic Medicine through rare diseases research in Africa

PROJECT SUMMARY
About 3.5–5.9% of the world population could be affected by a rare disease, corresponding
proportionally to 3.79–6.39 million people in the Democratic Republic of Congo (DRC). The
distribution of rare diseases is not uniform across countries or sub-populations. This uneven
distribution suggests that each country or region should determine the frequency and
distribution rare diseases within its borders and develop a prevention, screening,
management, and advocacy plan.
Interestingly, knowledge generated in one country or region is highly important in advancing
genomic medicine in other countries as well. African data are underrepresented in the vast
majority of reputable databases. Since the ability to make discoveries increases with data,
this paucity of African data prevents discoveries in Africa and improvement of diagnostic and
care for rare diseases patients.
Besides, African countries such as the Democratic Republic of Congo (DRC) are in a very
good momentum. First, the genomic diversity is higher in Africa. Second, the technological
barriers are being broken with the advent of the Cloud and the deployment of bioinformatics
tools and other resources in the Cloud. Third, the mobile internet has been broadly deployed
in the DRC and other Sub-Saharan countries, which is facilitating access to high computing
resources in the Cloud and removing the need for heavy local infrastructure or senior
bioinformaticians to conduct bioinformatics analysis in Sub-Saharan countries. Finally, the
expertise for rare diseases genomics has increased significantly in DRC, leading to multiple
research projects involving the analysis of genomic data being performed in the center for
human genetics of the University of Kinshasa.
However, poor quality data leads to wrong policies. An effort still needs to be made in building
networks to increase the quality and volume of data. This requires the harmonization of tools
and procedures for data collection and processing.
The African Rare Diseases Initiative (ARDI) is designed to be a model of how a Sub-Saharan
African country may become ready to enter the genomic medicine era and make significant
contributions to global genomic medicine. We will take advantage of the opportunities listed
above. Once this project is completed, the first expert network for rare diseases will be
effective in a Sub-Saharan African country and Congolese patients will have been
diagnosed. The first mobile App and electronic registry of African rare disease patients will
be implemented in a Sub-Saharan African country. The feasibility of analysis of genomic data
from Africa in the Cloud will be demonstrated at a broader scale. Our collaborations with the
UDNI, the ClinGen, the FDNA, the Baylor College of Medicine, and the Broad Institute will
offer assurance of the quality of data generated in this project. On the scientific front, the
epidemiology and underlying genetics of rare diseases in Africa will be revealed. We will use
the publications, ClinVar, DECIPHER and the Atlas of Human Malformation Syndromes in
diverse populations to contribute to the global genomic medicine community. The registry
will allow more disease-specific research to be conducted.
The model developed in this project is expected to be taken up by the government and be
replicated in countries with similar challenges.

Public health relevance
PROJECT NARRATIVE About 1 in 20 individuals in the world could be affected by a rare disease. A good care starts with a good diagnostics. Unfortunately, people from Low and Middle-Income Countries (LMICs) do not have access to good diagnostics. The situation of rare diseases in those countries is globally unknown. Genomic medicine consists in using genomic information to make health decisions. The fact that little is known from some parts of the world prevents those parts of the world from having access to good genomic medicine. By helping rare diseases patients in the Democratic Republic of Congo (DRC), we will also help patients in other regions of the world as well. The DRC is a genomically rich country, where experienced clinical geneticists trained oversee are now available and mobile internet has become available. We are a group of Congolese researchers who have come together to build a network that will generate good quality information and will improve the diagnosis in Congolese rare diseases patients, while also helping non-African patients across the world. We will also develop a model and tools applicable to other LMICs willing to embrace genomic medicine.